PULSATILE GH/PROLACTIN SECRETION IN NORMALS AND PATIENTS WITH PITUITARY ADENOMAS

This study examines the pulsatile secretion of pituitary hormones in normal individuals and in patients with documented functioning pituitary adenomas before and after curative surgical adenomectomy.